Comparison of Symptom Burden/Toxicity, Neurocognitive Change, and Functional Outcomes in Pediatric Brain Tumor Patients Treated with Proton vs. Photon Radiotherapy.

PROJECT SUMMARY
Most children treated for cancer in the US will achieve long-term survival, and survivorship presents unique
challenges for this growing population. Pediatric brain tumor survivors, in particular, are at risk for
neurocognitive impairments, educational difficulties, social problems, and medical disabilities. Cranial radiation
therapy is an essential lifesaving treatment but is associated with cognitive decline. Proton beam radiation
therapy (PBRT) is one of the most promising recent advances in pediatric brain tumor treatment. The proposed
medical advantage of PBRT lies in the precision of radiation delivery with proton beams, depositing maximum
dose to clinical targets while minimizing radiation to surrounding tissues. By reducing dose to healthy brain
tissue, PBRT may spare cognitive functioning and reduce symptom burden better than conventional photon or
x-ray irradiation (XRT) leading to greater functional independence in survivorship.
Using a model-based, accelerated longitudinal cohort comparison design, we will compare symptom
burden/toxicity, neurocognitive change, and functional outcomes at multiple data points from start of radiation
through late survivorship in patients treated with PBRT versus XRT. The following aims are proposed: (1) to
compare symptom burden and toxicity by RT type in pediatric brain tumor patients and survivors, (2) to
compare change in neurocognitive outcomes over time by RT type, (3) to compare functional outcomes in
early and late survivorship by RT type, and (4) to examine relations among symptom burden/toxicity,
neurocognitive function, and functional outcomes as a function of RT type.
This proposal is consistent with NCI’s objective to “reduce the long-term adverse effects of cancer and its
treatment” in children and to “improve the quality of life for cancer patients, survivors, and their families.”
Neurocognitive late effects lead to significant educational, social, and occupational limitations for many
survivors, greatly affecting their quality of life and functional independence long-term. Research is needed to
determine which treatments are best able to limit the suffering associated with symptom burden and post-
treatment neurocognitive decline. Our results will have clinical value, providing a timely comparison of
symptoms, neurocognitive changes, and functional outcomes between PBRT and XRT groups that will guide
clinicians and families on the range of outcomes to expect after PBRT.

Public health relevance
PROJECT NARRATIVE Many consider proton beam radiotherapy (PBRT) to be a promising treatment for children with brain tumors as it may preserve cognitive functioning without sacrificing disease control. This will be the first large-scale study to prospectively compare symptom burden, treatment toxicity, and neurocognitive change between patients treated with PBRT vs. conventional photon radiotherapy on comparable treatment protocols and to assess important measures of daily functioning that will quantify the clinical significance of any differences identified between groups in survivorship. Ultimately, this line of research is intended to: (1) help physicians and families better understand the relative effect of PBRT on symptoms and neurocognitive functioning to inform treatment decisions, and (2) provide functional outcome data to be used toward justifying or reconciling the high cost and access limitations currently associated with PBRT.